Targeting the Pathophysiology of Sickle Cell-Related Kidney Disease Using SGLT2 Inhibitors

Project Abstract
Chronic kidney disease (CKD) is present in over 50% of adults with sickle cell disease (SCD) and is associated
with increased morbidity and early mortality. However, the mechanisms underlying the development of SCD-
related CKD are poorly understood and therapies to prevent and treat SCD-related CKD are urgently needed.
Our group has reported that dysregulated tubuloglomerular feedback and proximal tubular stress may be
implicated in the pathophysiology of SCD-related CKD. This proposal will leverage our robust preliminary data
to target these mechanistic pathways using sodium-glucose cotransporter-2 inhibitors (SGLT2i), a class of
drugs representing one of the largest advances in CKD treatment for the general population, although its
impact on CKD in people with SCD has not yet been evaluated. SGLT2i have kidney-protective mechanisms
that overlap with pathways implicated in SCD-related CKD, including reactivating tubuloglomerular feedback
and ameliorating proximal tubular stress, making this class of therapy an ideal candidate for developing a
targeted approach to treat SCD-related CKD. Our group has also demonstrated that kidney functional
magnetic resonance imaging (fMRI)-derived perfusion, oxygenation, and fibrosis are able to differentiate
patients with CKD from healthy volunteers. In the proposed study, we will leverage this noninvasive tool to gain
valuable in vivo insights on the impact of SGLT2i in patients with SCD-related CKD. We will test our hypothesis
that SGLT2i ameliorates critical pathophysiologic processes in SCD-related CKD via two specific aims.
Specific Aim #1 will utilize a transgenic SCD mouse model to evaluate whether the SGLT2i, empagliflozin,
improves biomarkers of kidney function and injury (subaim 1) as well as fMRI, histopathology, and gene
expression patterns (subaim 2). Specific Aim #2 will investigate whether empagliflozin improves candidate
biomarkers of tubuloglomerular feedback and proximal tubular stress (subaim 1) and kidney fMRI-derived
perfusion, oxygenation, and fibrosis measures (subaim 2) in a pilot study of SCD patients with CKD treated for
48 weeks. Integrating biomarkers for candidate mechanistic pathways with fMRI will lead to a deeper
understanding in the pathophysiology of kidney damage and guide therapeutic strategies for SCD-related
CKD. This research team is exceptionally positioned to achieve the goals outlined in this proposal. In addition
to our strong history of productivity in SCD-related CKD research and fMRI-related research, we have a robust
institutional environment at the University of Illinois Chicago Comprehensive Sickle Cell Center that cares for
over 800 SCD patients and has a long-standing tradition of successful implementation of research studies.
Developing a better understanding of the pathways and effects of SGLT2i for treating SCD-related CKD has
the potential to have a significant impact on this underserved, high-risk population.

Public health relevance
Project Narrative Sickle cell disease (SCD) is among the most common monogenetic diseases worldwide and chronic kidney disease (CKD), which occurs in more than half of adults with SCD, is associated with high mortality. The goals of this proposal are to identify whether mechanisms for SCD-related CKD improves with sodium-glucose contransporter-2 inhibitors, a therapy approved to treat CKD but with unclear efficacy in people with SCD. Findings from this proposal will facilitate future development of interventional strategies to prevent and treat SCD-related CKD.